Longitudinal associations of maternal mobile device use and maternal-infant wellbeing

PROJECT SUMMARY
Sensitive and responsive caregiving interactions in early childhood, characterized by appropriate responses to
a child’s cues, provide the foundation for healthy emotional and behavioral development across the lifespan.
Infancy is a particularly critical period for these sensitive interactions with caregivers, given the important
contribution of these interactions to the development of infants’ ability to self-regulate. Infants learn to self-
regulate through co-regulation with the mother; therefore, supporting maternal wellbeing and healthy maternal-
infant co-regulation is an important strategy for promoting emotional and behavioral development. One
evolving and modifiable threat to these sensitive interactions is the mobile device, which has become deeply
interwoven into the fabric of family life, with nearly universal adoption. A growing body of evidence suggests
that due to their engaging design and portability, mobile devices may uniquely interfere with a caregiver’s
ability to sensitively respond to their young children’s cues. This prior work, however, has not examined in a
comprehensive model during infancy potential pathways of association between maternal mobile device use,
maternal wellbeing, infant regulation, and maternal-infant co-regulation. Examining these potential associations
among low-income, first-time mothers and their infants may be especially important, given the buffering role
that sensitive maternal-infant interactions can have against psychosocial stress and the patterns of caregiving
that become established during the transition to motherhood. Examining these pathways of association
longitudinally across infancy would allow for identification of both key targets for intervention and the critical
developmental periods during which to intervene upon these targets. Therefore, in a cohort of 230 low-income,
first-time mother-infant dyads, we will measure maternal mobile device use, maternal wellbeing, infant
regulation, and maternal-infant co-regulation at three time points in infancy to address the following aims: Aim
1: To characterize maternal mobile device use with regard to quantity, type of app, and intent. Aim 2: To test
pathways of association between maternal mobile device use, maternal wellbeing, infant regulation, and
maternal-infant co-regulation at infant ages 3, 6, and 12 months. Aim 3: To identify temporal relationships
between maternal mobile device use, maternal wellbeing, infant regulation, and maternal-infant co-regulation
across infant ages 3, 6 and 12 months. The PI, Dr. Munzer, is a developmental-behavioral pediatrician whose
growing research program seeks to understand parenting in the digital age, and how it contributes to children’s
wellbeing. With the support of a multidisciplinary team of mentors, Dr. Munzer will gain experience in mobile
device sampling; observed and reported measures of maternal wellbeing, infant regulation, and maternal-infant
co-regulation; and structural equation modeling, cross lagged analyses, and imputation. At the conclusion of
the award period, Dr. Munzer will be poised to develop and test an intervention designed to promote sensitive
maternal-infant interactions and healthy infant emotional and behavioral development in the digital age.

Public health relevance
PROJECT NARRATIVE Adoption and use of mobile devices have each grown exponentially in the last decade and mounting evidence suggests that mobile devices may uniquely interfere with a parent’s ability to sensitively respond to their child’s cues. These sensitive interactions are especially important in infancy and for low-income families, creating the foundations for social-emotional development that last a lifetime. This proposal seeks to address gaps in knowledge by understanding how first-time, low-income mothers use mobile devices, and the potential associations of mobile device use with maternal wellbeing, infant regulation, and maternal-infant co-regulation, in order to ultimately promote the health of children in infancy and beyond.